Biobehavioral Measurement Core

ABSTRACT
Biobehavioral Measurement Core (Anna Marsland, CL)
The objective of this Program Project is to elucidate the neurobiology of midlife disparities in cardiovascular
disease (CVD) risk. Primary outcomes lay in 2 broad domains: (1) preclinical vascular disease and dysfunction
and (2) cardiometabolic risk. Secondary outcomes are incident CVD events, hypertension, and type 2 diabetes.
All projects (P's) postulate common proximal mediators of CVD risk, including health behaviors (e.g.,
substance use, customary diet, physical activity, and sleep), as well as candidate biomediators of autonomic
control, systemic inflammation, endothelial and HPA-axis function, and oxidative stress. To enable uniform
data collection and synergy across Ps, the Core B team will collect, verify and monitor shared Program
outcomes and mediators, transfer data to Core C, and continuously report subject-by-subject protocol
adherence to Core A. Core B will also oversee the quality assurance of all biobehavioral measures, provide
centralized storage of biological specimens relevant to longitudinal testing, offer consultation and education on
biobehavioral measures to all P teams, and assist with interpreting findings. For longitudinal analyses, all
measurements obtained at T1 that address the aims of P's 1-3 will be re-obtained at follow-up assessments, and
new or expanded measurements will be obtained as is feasible and advantageous to capture sentinel predictors,
mediators and outcomes impacting CVD risk. We will collect data on 899 people recruited to P's 1-3. Core B is
led by Dr. Marsland, Director of the Behavioral Immunology Laboratory where biological samples will be
processed and stored. She is assisted by a Core Medical Director and Ambulatory Division Leader. The Medical
Director is a physician who will assume oversight of participant-reported clinical diagnoses and events, as well
as participant safety monitoring and associated risk mitigation strategies. The Ambulatory Division Leader will
provide oversight of all ambulatory measures commonly obtained in the Program cohorts, including ecological
momentary assessment diary data, ambulatory blood pressure, and actigraphy data.

Public health relevance
PROJECT NARRATIVE Biobehavioral Measurement Core The Biobehavioral Measurement Core will collect, score, verify, and monitor biological and behavioral data for this research program. Data include outcome measures of preclinical vascular disease and dysfunction, cardiometabolic risk, incident cardiovascular disease, hypertension and type 2 diabetes mellitus, as well as proximal mediators that are common to all projects, subsuming health behaviors and biomediators. The Core will ensure that the public health benefits derived from the information generated by the research program will be realized and disseminated.